Limited Competition for the Continuation of the Chronic Renal Insufficiency Cohort (CRIC) Hopkins Clinical Center

This application is submitted in response to RFA-DK-17-506, “Limited Competition for the Continuation of the
Chronic Renal Insufficiency Cohort (CRIC) Clinical Centers (U01),” for the Hopkins/University of Maryland
(Hopkins/UMB) Clinical Center. Over Phases 1-3 of CRIC (2002-16), the study enrolled 5,499 adults with
chronic kidney disease (CKD) at 7 Clinical Centers to address the overarching goals of identifying risk factors
for CKD progression and clarifying the relationship between kidney dysfunction and its consequences,
particularly cardiovascular disease and mortality.
In Phase 4 of CRIC (aka CRIC 2018-23), the Hopkins/UMB center has the following specific aims:
1. To re-enroll current participants [~415 anticipated (~370 without ESRD, ~45 with ESRD)]
2. To collect exposure and outcome data per the CRIC Phase 4 protocol
3. To maintain high levels of retention in the study
4. To investigate self-reported clinical events and obtain supporting medical records and documentation.
5. To enter data and collect/process/ship biological specimens
6. To implement local quality assurance and quality control procedures as a means to obtain
standardized, high quality measurements
7. To monitor data collection, data entry, and follow-up rates
8. To participate in governance and oversight of CRIC through study-wide subcommittees and activities
9. To publish and present findings from the CRIC Study
10. To promote and support the conduct of ancillary studies in CRIC
11. To engage investigators at the Hopkins/UMB investigators to assist in local analysis of CRIC data
12. To engage investigators in the broader scientific community
The investigative teams at Hopkins and UMB have vast experience in the design and implementation of
rigorously conducted, influential research. During Phases 1 to 3, the Hopkins/UMB Center was a high
performing center that exceeded its recruitment goals; achieved high follow-up rates; and collected high quality
data. Likewise, center investigators have consistently had prominent leadership roles (e.g. Co-Chairs of
Recruitment and Retention, Ancillary Studies, and Publications Executive Subcommittees). In Phase 4, we
remain extremely well-positioned to successfully implement the study. On a final note, we remain deeply
committed to the success of CRIC and look forward to providing strong scientific leadership in this
tremendously important research effort.

Public health relevance
Chronic Kidney Disease is an extremely common medical problem. The consequences of chronic kidney disease include kidney failure requiring dialysis or a kidney transplant; cardiovascular disease and stroke; physical and cognitive disabilities; and premature death. The Chronic Renal Insufficiency Cohort (CRIC) Study is a long-term, observational study designed to evaluate factors that might be responsible for these adverse outcomes in adults with chronic kidney disease.